Discovery of functional cell types in the inferior colliculus with combined molecular-genetic and electrophysiological approaches

Project Summary The central nucleus of the inferior colliculus (ICC) is a midbrain nucleus that serves as a pivotal point of convergence for a large number of ascending and descending auditory pathways. Understanding how computations carried out in the ICC relate to the underlying circuitry has been unusually difficult, in large part due to the lack of clear definitions of cell types. Indeed, there appears to be no correlations between intrinsic firing properties and cell morphology, even across excitatory and inhibitory cells. We propose that functionally distinct classes of neurons in the ICC can be identified and genetically accessed using viruses with promoters to different neurochemical markers. To address this hypothesis, we will combine electrophysiological and anatomical approaches with interdependent recombinant adeno-associated viruses (rAAV) targeting excitatory and inhibitory classes of calbindin D-28k ICC neurons (CB-excitatory and CB- inhibitory). CB is a calcium binding protein expressed in subsets of neurons of the ICC and in many other brain areas. Our preliminary results show that viruses carrying a CB promoter element target ICC neurons that exhibit a single firing phenotype, and that these neurons may comprise both excitatory and inhibitory subclasses. In Aim 1, we will combine in vivo labeling of ICC neurons with rAAV viruses, fluorescence guided patch recordings in IC slices, and anatomical analyses to fully characterize the two pools of CB neurons, including their physiology, morphology and axonal projections. In parallel, labeled neurons will be characterized according to their complement of expressed neurochemical markers. In Aim 2, we will use our molecular-genetic tools to drive channelrhodopsin-2 selectively in CB-excitatory or CB-inhibitory neurons. We will use structured illumination to map CB neurons' local inputs and targets in the ICC as well as to facilitate paired whole-cell patch recordings from connected neuron pairs, enabling characterization of synaptic properties between physiologically identified network partners. These experiments will serve as a blueprint for identifying and characterizing other functionally distinct circuits in the ICC. Our goal is to establish a foundation for future studies involving cell-specific optogenetic manipulations in vivo, where we can assess the roles of CB neurons and other defined ICC cell types in auditory computations.

Public health relevance
Project Narrative The central nucleus of the inferior colliculus is a critical auditory station that mediates the convergence of both spatial and non-spatial auditory information. An understanding of the fundamental nature of this processing and the roles of the underlying circuit elements is a prerequisite for understanding how this area is affected by hearing loss and other communication disorders such as tinnitus.